Lens Epithelial Cell Response to Biomaterial Interfaces

PROJECT SUMMARY
Cataract remains the leading cause of blindness worldwide with over 3 million extractions performed each year
in the United States alone. During cataract surgery, the contents inside the lens capsule are removed through a
hole in the anterior lens capsule and a polymeric intraocular lens (IOL) is placed in the capsule. The leading
vision-threatening complication, posterior capsule opacification (PCO), occurs when residual lens epithelial cells
(LEC) migrate from the anterior to the posterior lens capsule or onto the IOL and undergo epithelial-to-
mesenchymal transition (EMT). While several factors impacting mechanobiology and epithelial cell response
have been previously investigated, there is not a clear understanding of the impact of viscoelasticity and
curvature on LEC behavior. The overall objective of this project is to use polymer and hydrogel substrates that
mimic the implants and lens microenvironment, respectively, to better analyze the influence mechanical
properties have on LEC response and EMT. It is hypothesized that the physical and mechanical properties of
the microenvironment are altered after the removal of the lens tissue and IOL placement, facilitating EMT in LEC.
In Aim 1, tunable polymer substrates and hydrogels will be used to investigate the impact of stiffness and
viscoelasticity on LEC response and EMT. It is hypothesized that substrates stiffer than the lens capsule, and
substrates with lower loss tangent will drive EMT in LEC. In Aim 2, the effect of substrate curvature will be
investigated using the same polymer and hydrogel substrates. The governing hypothesis is that LEC migration
and EMT are driven by larger radius of curvature caused by flattening of the lens capsule after IOL implantation.
Curvature effects will be evaluated using polymers micropatterned with different radii of curvature. Glass
microbeads of various sizes will be embedded in hydrogel formulations, mimicking the changes in the lens
capsule shape following surgery. In both aims, relevant in vitro and ex vivo models will be used. LEC proliferation,
migration, and markers for EMT will be assessed. TGF-β and rapamycin will be used as positive and negative
inducers of EMT, respectively. RT-PCR will quantify gene expression, and changes in protein expression will be
evaluated using Western blot and immunofluorescence. Specific genes and proteins that will be evaluated
include SMAD signaling proteins, α-SMA, Slug, Snail, fibronectin, E-cadherin, and YAP. The goal of this project
is to determine how substrate mechanical properties, namely viscoelasticity and curvature, contribute to LEC
behavior and induction of EMT. This will significantly enhance our knowledge of LEC mechanobiology and the
role of these factors in EMT, suggesting strategies to prevent pathological EMT. The results will lead to future
research on design of materials to prevent EMT and fibrosis after implantation, particularly for preventing PCO.

Public health relevance
PROJECT NARRATIVE Following cataract surgery, a common complication called posterior capsule opacification (PCO) occurs when residual lens epithelial cells (LEC) migrate from the anterior to the posterior lens or onto the intraocular lens (IOL) and undergo epithelial-to-mesenchymal transition (EMT). The impact of substrate curvature and viscoelasticity on this process are poorly understood. The overall objective of this project is to determine how substrate viscoelasticity and curvature impact LEC behavior and EMT by using copolymers and hydrogels that mimic implants and the native lens microenvironment, respectively.